The Molecular Mechanisms of Immune Cell Development and Function

PROJECT SUMMARY
This proposal requests partial support for a 2023 Science Research Conference (SRC) sponsored by the
Federation of American Societies for Experimental Biology (FASEB) on the subject of “Molecular Mechanisms
of Immune Cell Development and Function”, the 11th conference in this highly successful series. This conference
has been chosen for sponsorship by FASEB after a competitive re-evaluation every other year since its inception
in summer 2003. The distinctive features of this conference are: (1) A strong emphasis on molecular biology of
gene regulation in immune cell development and function, including new insights emerging from genome-wide
and systems approaches; (2) Close integration of the study of molecular mechanisms of immune receptor gene
recombination and diversification with concepts in genomic architecture and long-range genomic control; (3)
Deliberate juxtaposition of research on different classes of immune cells to reveal larger patterns of shared use
of molecular and developmental mechanisms; (4) An explicit focus on gene network and signaling network
connections rather than “one gene at a time” studies to provide a comprehensive explanation of biological
regulation; (5) Creation of sessions that integrate the major molecular/mechanistic themes of the meeting with
immuno-oncology, gut homeostasis, and autoimmunity; (6) Integration of presentations from scientists at many
career levels, from internationally renowned experts to junior postdoctoral fellows and graduate students, in an
intensive, all-plenary program—allowing trainees easy access to experienced senior scientists who in turn gain
an appreciation of the young people’s impact on the field, and (7) Implementation of our unique financial model
in which invited speakers forego financial support for their participation to allow the use of the majority of funds
to support trainees and young investigators who are establishing their independent careers. These distinctive
features are designed around three specific aims: Aim 1—To disseminate the most recent and important
advances and new paradigms in molecular immunology; Aim 2—To create a highly interactive, supportive, and
collegial environment for the sharing of scientific knowledge between scientists at many different stages of
training and career development, thereby facilitating new collaborations, broadening of professional and
mentoring networks, and career development; and Aim 3—To enhance diversity among the individuals who
participate in, contribute to, and achieve career advancement in the field of immunology and biological research
more broadly. The support requested is crucial to make it possible for the most promising trainees and junior
faculty in molecular immunology to publicly present their work in plenary sessions and interact in a small setting
with leaders in their field. This meeting has received enthusiastic feedback from conference attendees of
previous meetings, giving it a strong mandate for long-term continuation.

Public health relevance
PROJECT NARRATIVE This proposal is to request renewal of support for a conference in molecular immunology that has been organized associated with the Federation of American Societies for Experimental Biology (FASEB) Science Research Conferences (SRC) every other year since 2003. The conference, called Molecular Mechanisms of Immune Cell Development and Function, brings together experts on multiple different types of immune system cells to compare and contrast the molecular mechanisms that explain and control immune functions. Continuing support is especially valuable to ensure that younger scientists, women, and scientists from historically underrepresented backgrounds can have their discoveries showcased in plenary sessions along with work of established national and international experts.